Adult Changes in Thought - Biorepository

SUMMARY
This revision to the Adult Changes in Thought (ACT) U19 Program adds a new aim (Aim 3) to enrich the ACT
Program by establishing a blood-based biorepository. The parent U19 award transformed ACT from a U01 to a
U19 program, modernizing and expanding ACT’s prospective cohort study to achieve advances in scientific
understanding of cognitive and brain health among older adults. ACT is set in a healthcare delivery system. It
enrolls dementia-free older adults and identifies incident cases of Alzheimer’s disease and related dementias
(ADRD), following consenting participants to autopsy. The Program’s overarching goal is to identify risk factors
across the life course that provide potential intervention targets for preserving cognition and preventing
Alzheimer’s disease and related dementias (ADRD). The Overall Specific Aims are: Aim 1. Expand ACT cohort
enrollment from 2,000 to 3,000 participants with emphasis on increasing racial/ethnic diversity and deep
phenotyping of life course risk factors, cognitive and physical functioning, and outcomes including
neuroimaging and neuropathology based ADRD outcomes. The program has 6 Cores: A, Administrative; B,
Clinical; C, Life Course; D, Neuropathology; E, Neuroimaging; F, Data and Analysis. These Cores will work
together to further enhance the value of ACT’s resources, enabling the ACT study to continue to be the
foundation for an extraordinary array of science. ACT has achieved a completeness of follow-up index of
94.5% and has observed > 56,000 person-years of follow-up. ACT has identified >1,300 incident dementia
cases and >1,000 incident Alzheimer’s cases. The study has completed 1000 autopsies and will surpass 1,100
autopsies this cycle. Additionally, >1000 ACT participants have one MRI scan, and ≥ 500 participants have ≥ 2
scans, with funding in place to scan more than 200 additional participants. Aim 2. Support key Projects
studying the spectrum of healthy functioning to ADRD in older adults. The three Projects center around 24-
hour cycle physical activity, sedentary behavior, and sleep patterns (Project 1), the implications of cognitively
defined Alzheimer’s disease subgroups (Project 2), and mechanisms underlying neural protection and toxicity
of anticholinergic drugs and antihypertensive drugs (Project 3). Aim 3. (new to this revision): Establish a fit-for-
purpose blood-based biorepository using best practices for ADRD research to measure current state-of-the-art
plasma ADRD biomarkers and share biospecimens to enable future proteomic and transcriptomic research.
Aim 4 Expand and improve ACT’s dissemination of exceptional resources to the research community guided
by NIA’s adopted FAIR (Findable, Accessible, Interoperable, and Reproducible) principles. ACT has proven to
be an exceptional resource to the research community, providing data and specimens to research colleagues
locally, across the country, and around the world, and provides mentorship to junior investigators.

Public health relevance
NARRATIVE The Adult Changes in Thought (ACT) U19 Program seeks to improve understanding of cognitive and brain aging and dementia risk by following a cohort of older adults enrolled from a healthcare delivery system with extensive records from clinical care. Cognitively healthy participants are followed until death, dementia, or discontinuation, with about one third of the cohort consenting to autopsy. The addition of a blood-based bio- repository through this revision will enable assessment of biomarkers of Alzheimer’s disease and age-related pathologies, which will accelerate research into identifying strategies for delaying or preventing dementia, and will substantially increase the value of the ACT study for future collaborative research.